AN OPEN LABEL STUDY OF CV205-502 HYPERPROLACTINEMIC PATIENTS

The objective of this double-blind study is to determine the oral doses at which CV 205-502 exerts an anti-hyperprolactinemic effect in patients with hyperprolactinemia.